Using Novel Machine Learning Methods to Personalize Strategies for Prevention of Persistent AKI after Cardiac Surgery

My long-term goal is to integrate health informatics, data mining and machine learning to improve the care for
patients with, and at risk for, acute kidney injury (AKI). I am dual trained in Nephrology and Critical Care
Medicine. I am already developing my skills in health informatics. This proposal presents a five-year career
development plan for NIH K08 award focused on training in advanced data mining, machine learning and their
applications to critical care nephrology. To that effect, I have assembled a strong mentoring team with decades
of experience in mentoring, research and leadership. The outlined career development plan in conjunction with
intensive mentoring and hands-on training will provide me the perfect platform to become a leading
independent investigator in the field.
AKI, a complex syndrome with heterogenous phenotypes, is seen in over one third of patients undergoing
cardiac surgery. Though increasing severity of AKI is associated with worse outcomes, preliminary literature
has shown than persistence of AKI is itself important. While transient AKI that resolves rapidly still has worse
outcomes, the outcomes are much worse for patients with persistent AKI that lasts beyond 48 hours.
Additional monitoring, reassessment of causes and management options is recommended once the diagnosis
of persistent AKI is established. The prevention of AKI, however, remains paramount. Preventive actions,
though effective, have low compliance among cardiac surgery patients. As over 40% of AKI after cardiac
surgery is transient and resolves spontaneously within 48 hours, targeted application of these actions in
patients at high risk for developing persistent AKI will allow for a more focused allocation of resources.
Identification of distinct phenotypes among patients with persistent AKI will further allow for identification of
differential responses to therapy and lead to personalization of AKI therapy. The current AKI research,
however, is focused on identification and prevention of increasing severity of AKI. The objective of this study
therefore is to identify and characterize patients at risk for and with persistent AKI after cardiac surgery. This
will be accomplished by addressing the following two specific aims: (1) Develop digital biomarkers to predict
patients at risk for persistent AKI after cardiac surgery, (2) Determine distinct clinical phenotypes among
patients who develop persistent AKI after cardiac surgery. Completion of these aims will provide a structured
framework to provide personalized care to patients with AKI. It will also provide me with preliminary data and
experience necessary to apply for R01 application as an independent investigator leading a data science
research program in critical care nephrology.

Public health relevance
Acute kidney injury (AKI) complicates over one-third of admissions for heart surgery and is associated with high morbidity, mortality and doubling of healthcare costs. When compared to AKI that resolves rapidly, its persistence is associated with much worse outcomes, however, current studies do not address this issue. This project will use novel applications of advanced data mining and machine learning to predict and characterize patients who develop persistent AKI after heart surgery.